Modified Use of E-cigarettes and Marketing on YouTube

PROJECT SUMMARY
E-cigarette use among U.S. youth is a significant public health problem. Understanding youth appeal of e-
cigarettes and marketing strategies targeting youth is critical to inform the U.S. Food and Drug Administration
(FDA)’s goal to prevent youth e-cigarette use. A significant youth appeal is the ability to modify e-cigarettes or
to “hack” the devices or e-liquid constituents for unintended purposes (e.g., using at higher temperatures or for
a longer period of time, adding their own e-liquids made with nicotine or THC oil). However, it is largely
unknown how youth modify e-cigarette devices or their components, their perceptions of these behaviors, and
marketing strategies used to endorse these behaviors. YouTube, a popular social media, can be examined to
understand modified uses of e-cigarettes and marketing associated with these behaviors. The overall goal of
this study is to understand ways in which youth modify e-cigarettes, their motivations for doing so,
and marketing sources, using YouTube analysis, survey methodology, and expert evaluation. We will
identify modified uses of e-cigarettes and marketing using fictitious youth YouTube viewer profiles to search for
e-cigarettes using a browser plug-in and custom scripted web-crawling and then machine learning to
automatically code the videos to identify e-cigarette modifications and marketing source. Our Advisory
Committee (AC) of subject matter experts in tobacco regulatory science, social media, youth tobacco use,
toxicology, communications, and tobacco marketing will apply their knowledge to assess the potential impact of
these identified modified uses on appeal, addiction, and health effects of e-cigarettes to identify those which
are amenable to FDA regulations and communications. We will then conduct an in-depth analysis of these
selected behaviors using a combination of machine learning and detailed human coding on youth-accessible
YouTube videos to understand: 1) components that are modified (e.g., batteries, cartridges/pods, e-liquids), 2)
motivations for modification (e.g., enhance user experience, reduce perceived harm), 3) marketing sources
(e.g., online shops, pro-e-cigarette organizations), and 4) appeal (number of likes, views). We will also use an
online survey with adolescent and young adult e-cigarette users (N=1000) to examine the prevalence, appeal,
motivations, risk perceptions, and marketing exposure related to these modified uses and their predictors (i.e.,
demographic variables, past-month e-cigarette use frequency, e-cigarette dependence, other
tobacco/substance use, interpersonal and intrapersonal risk factors). The results of this study will provide the
FDA with novel evidence to 1) develop regulations to prohibit the manufacturing and marketing of e-cigarette
components that can be modified by youth, 2) restrict youth-accessible marketing of e-cigarettes on social
media such as YouTube, and 3) develop prevention campaigns to educate youth about the harms of modifying
e-cigarettes.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE: E-cigarette use among youth is high; thus, to inform youth e-cigarette prevention, we will examine the youth appeal of the product, such as the ability to modify or “hack” the devices and their related components for unintended uses and marketing on popular social media, YouTube. We will use mixed-methods (i.e., machine learning, survey methodology, expert evaluation) to achieve our aim. The results of this study will provide the FDA with novel evidence to develop regulations to prohibit the manufacturing and marketing of e-cigarette components that can be modified, restrict youth-accessible marketing of e-cigarettes on YouTube, and develop prevention campaigns to educate youth about the harms of engaging in these behaviors.